SALIVA COTININE LEVELS IN SOUTHEAST ASIAN SMOKERS

No studies have reported cotinine levels in Southeast Asian populations. This first part of this study will quantitate cotinine levels in southeast asian smokers in a well-controlled laboratory environment. The second portion will measure cotinine levels in southeast asian smokers during smoking and after cessation in a field setting.